CORE--GENERAL LABORATORY SUPPORT FACILITIES

The General Laboratory facility Core will breed and maintain all Ncr nu/nu mice in the Department of Experimental Radiation Oncology specific pathogen free (virus negative) mouse colony for all in vivo experiments. This core will also provide for the production of routine histology/immunohistochemistry of human tumor xenografts. Lastly, it will provide for the design and manufacture of custom jigs for irradiation of mice and perform dosimetry for all proposed radiation experiments.